Resource Based Center for Musculoskeletal Biology and Medicine (Overall Application)

Summary/Abstract - Overall
One in two adults in the United States has a prevalent musculoskeletal condition, with related costs of $900
billion annually. To address this crisis, efficient utilization of resources and sustained commitment to basic
and translational research are essential. We propose the Washington University Resource-Based Center for
Musculoskeletal Biology and Medicine, dedicated to two long-term goals – to advance research on the
biological basis of musculoskeletal disease, and to develop and test biologically based intervention
strategies. We represent a dynamic Research Community of 81 investigators, affiliated with 17 academic
departments. Since 2009, the Center has contributed to 343 publications that have been cited 6687 times.
The annual external funding of Center investigators is $66.2 million, including $8.1 million from NIAMS. Our
work focuses on the most prevalent and costly musculoskeletal disorders – arthritis, back pain, bone and
joint trauma, osteoporosis, and metastatic cancer. Notably, the majority of our research endeavors are in
basic and pre-clinical studies. Therefore, our overall objective is to support the Research Community in the
development, implementation and evaluation of animal models for musculoskeletal biology and medicine.
We will address this objective through four integrated Aims. Aim 1. Through an Administrative Core (A),
provide Center leadership to manage the Cores and engage in outreach. Direct an Enrichment Program
that will foster the development of the next generation of musculoskeletal investigators through a Pilot &
Feasibilty program, seminars, symposia and other activities. Aim 2. Through the Musculoskeletal Structure
and Strength Core (B), support access, training and cost-effective utilization for: i) x-ray based imaging
methods to quantify morphology, and ii) biomechanical methods to quantify mechanical properties of
musculoskeletal tissues (bone, tendon, muscle, cartilage, disc). Aim 3. Through the Musculoskeletal
Histology and Morphometry Core (C), perform tissue processing, embedding, sectioning and staining,
protocol maintenance and user training appropriate for the range of tissues/techniques required in
musculoskeletal research. Support access and training for routine and advanced microscopy and
histomorphometry. Aim 4. In the Animal Models of Joint Injury and Disease Core (D), provide training and
implementation for reproducible mouse models of osteoarthritis and rheumatoid arthritis. Measure in vivo
biomechanics and behavior to assess joint pain and function. Create a repository of tissue and serum
samples from arthritic mouse models. In summary, the four Cores we propose will provide essential support
for our Research Community to develop, implement and evaluate animal models for musculoskeletal
biology and medicine. A common theme for each Core is to support training and enrichment activities to
foster development of the next generation of musculoskeletal investigators.

Public health relevance
Project Narrative - Overall Musculoskeletal conditions affect one in two Americans. We are a group of 80+ researchers who study the underlying causes for musculoskeletal diseases like arthritis, back pain and osteoporosis. With this knowledge, we develop and test new strategies to treat these diseases, primarily using small animals to test proof of concept.